A methyl arginine targeting chimera for the lysosomal degradation of intracellular proteins

PROJECT SUMMARY/ABSTRACT
Targeted-protein degradation (TPD) is a novel modality that harnesses cellular proteolysis to eliminate
disease-causing proteins. Proteolysis-targeting chimeras (PROTACs) are small molecule degraders that
induce proximity of the proteasomal machinery with a substrate. Such approaches hold the promise to
revolutionize modern medicine as they target classically undruggable families that lack active sites and offer
safer therapeutic windows due to their catalytic pharmacology. However, PROTACs are limited by the capacity
of proteasomes. A multi-step assembly of ubiquitin ligases precedes POI ubiquitination, further complicating
degrader design and efficacy. Additional challenges include acquired lysine mutations, a small fraction of
available E3 ligases, and an inability to effectively troubleshoot the events leading up to proteasomal
degradation. Thus, several limitations must be addressed before the potential of degrader modalities can be
fully realized. Lysosomes are the alternative degradative route and have been exploited for extracellular
proteins by Lysosomal Targeting Chimeras (L YTACs). These exciting developments highlight the potential of
lysosomes to combat the central limitations of proteasomal degraders, but are wholly restricted to extracellular
proteins. Degraders of intracellular proteins rely on ubiquitin modifications that direct proteins to proteasomes.
Recent work shows that arginine methylation modifications direct proteins to lysosomes during normal
homeostatic maintenance in unmodified, natural conditions. Preliminary work shows that this pathway can be
activated through proximity between a substrate and a protein arginine methyltransferase. We hypothesize
that chemically inducing arginine methylation will be sufficient to target diverse protein classes for
degradation in lysosomes. The proposal's main goals are to characterize the mechanisms for applying this
degradation route synthetically (Aim 1) and to identify endogenous substrates of this degradation pathway that
may later be amenable to synthetic degradation (Aim 2). The outcome of this study will generate a degrader
modality that is independent of ubiquitin and offer insight into endogenous networks of protein homeostasis.
This research holds long-term potential to improve therapeutic tractability across diverse disease states.

Public health relevance
PROJECT NARRATIVE Targeted protein degradation is a revolutionary new class of therapeutics that eliminates, not just inhibits, disease-causing proteins from the cell. The field currently depends on one degradation pathway, the proteasome, which is burdened with limitations that leave many disease targets undruggable. This proposal leverages a recently discovered pathway for degradation in lysosomes, which may offer a vital therapeutic tool to degrade any disease-causing protein.